Role of GPR173 in the central control of plasma volume expansion in pregnancy

PROJECT SUMMARY
Maintenance and completion of a healthy pregnancy requires profound physiological adaptations of maternal
physiology. In particular, the maternal plasma volume in a singleton pregnancy must expand by ~50% by 40
weeks of gestation to ensure proper placental perfusion to accommodate and support the growing offspring. In
the absence of appropriate plasma volume expansion (PVE), the pregnancy, and health of the mother, can be
compromised. For example, failure of PVE in pregnancy can lead to intra-uterine growth restriction or fetuses
that are small for gestational age. Central mechanisms underlying pregnancy-associated PVE include alterations
to drinking behavior and neuroendocrine regulation of vascular and renal function. In particular, the osmotic
thresholds for thirst and the release of arginine vasopressin (AVP) from the posterior pituitary are reduced in
pregnancy. We reported the discovery of a hypothalamic peptide, phoenixin (PNX), and the identification of its
receptor, GPR173, that appears to play important roles in the regulation of thirst and drinking behavior as well
as AVP secretion. In pregnant rats, PNX expression increases as pregnancy progresses, and correlates
significantly with AVP levels. Our preliminary data also suggest that knockdown of GPR173 in hypothalamus of
rats leads to fetuses that are significantly smaller than that of controls, consistent with reduced PVE in GPR173
siRNA-treated rats. We therefore hypothesize that PNX/GPR173 signaling contributes to pregnancy-associated
PVE through the regulation of AVP secretion and thirst. This hypothesis will be tested in two Specific Aims. In
the first Aim, we will use our established model of siRNA-mediated knockdown of PNX or GPR173 in
hypothalamus to evaluate the impact of loss of hypothalamic PNX signaling on basal and compensatory water
drinking and ingestive patterning in pregnant rats. We have previously shown that PNX stimulates water drinking
in non-pregnant rats via an interaction with the central angiotensin system. We therefore propose downstream
activation of angiotensin signaling as a potential mechanism by which PNX impacts drinking in the setting of
pregnancy. This will be assessed using pharmacological and molecular tools. In the second Aim, we will
investigate how loss of PNX signaling impacts the increase in AVP secretion during normal pregnancy. In
addition, using the method of Lindheimer and colleagues, we will investigate the role of hypothalamic PNX in the
resetting of the osmotic threshold for AVP release in pregnant animals. Lastly, we will investigate the molecular
mechanism underlying PNX’s actions in hypothalamus in the setting of pregnancy using biased (pharmacologic
and immunohistochemical) and unbiased (spatial transcriptomic, i.e., spatial molecular imaging) methods. The
successful completion of these proposed studies will offer insights into the basic biological mechanisms
underlying changes in plasma volume associated with pregnancy. This new knowledge will serve as the basis
of future experiments designed to investigate how changes in PVE in pregnancy lead to disease, as well as offer
potential therapeutic targets for common pregnancy complications.

Public health relevance
PROJECT NARRATIVE Pregnancy is associated with dramatic changes in the volume of blood of the mother, which helps the mother’s body properly support the growing fetus; without this increase in blood volume, the pregnancy and health of the fetus and mother can be compromised. We have identified a new hormone, called phoenixin, that could play an important role in regulating the changes in blood volume in pregnancy. Our goal is to understand how phoenixin contributes to changes in blood volume in pregnancy, so that, ultimately, diseases associated with low blood volume in pregnancy can be treated or prevented.